Systems Biology of Protein and Phenotypic Evolution

Project Summary/Abstract
An important and currently unsolved challenge in evolutionary systems biology is to
describe how the mechanisms and interactions between different levels of biological organization
shape the evolution of proteins, cellular networks, and phenotypes. Our laboratory has been
interested in understanding the inter-relationships between evolution and systems and cell biology
for more than a decade. We have previously carried out computational and experimental analyses
exploring evolutionary processes at multiple levels of organization. In this proposal we will
integrate constraints and effects at the protein, network, cellular, and phenotypic scales, towards
developing an integrated and quantitative framework describing protein evolution. We will use a
combined computational-experimental approach to pursue such fundamental scientific questions
as: How do global protein fitness landscapes affect short- and long-term patterns of protein
evolution? How do the structure and function of cellular networks affect protein evolutionary
changes? What is the role of cell type- and tissue-specific constraints on protein evolution? How
does the evolution of protein repertoires influence the observed patterns and rates of phenotypic
evolution? Because biological systems not only constrain, but are also themselves the products
of evolution, exploring the aforementioned topics will also allow us to address important biological
questions. For example, how and to what extent protein expression levels and the efficiency of
protein function are optimized in evolution, and how changes in cellular networks may drive
microbial phenotypic evolution. In addition to understanding fundamental biological questions,
proposal results will have important implications for biomedicine. Specifically, they will allow to
better understand and predict the quantitative effects of genetic mutations on protein function,
cellular networks, diverse cell types and developmental stages, and ultimately on species’
phenotypes.

Public health relevance
Project Narrative In the proposal we will integrate constraints and effects at multiple levels of biological organization towards developing an integrated and quantitative framework describing protein evolution. In addition to understanding fundamental biological questions, proposal results will have important implications for biomedicine. Specifically, they will allow to better understand and predict the quantitative effects of genetic mutations on protein function, cellular networks, diverse cell types and developmental stages, and ultimately on species’ phenotypes.